Understanding the role of the transcription factor Gli3 in Kallmann syndrome and normosmic forms of idiopathic hypogonadotropic hypogonadism

Project Summary
Puberty is a transformative developmental process resulting in sexual and reproductive maturity. Both the onset
of puberty and fertility in adult life depend on the activity of neurons expressing gonadotropin-releasing hormone-
1 (hereafter referred to as GnRH-1ns). Originating in the nasal placode during embryonic development, GnRH-
1ns migrate along axons to the hypothalamus, where they take up residence in the brain and regulate the release
of gonadotropins from the pituitary gland throughout life. Defective GnRH-1 neuronal development can cause
congenital hypogonadotropic hypogonadism (HH), and sex hormone deficiencies that can cause delays or the
absence of puberty, resulting in infertility. HH can manifest clinically as either (i) Kallmann syndrome (KS),
wherein HH is associated with different levels of olfactory deficits, or (ii) normosmic idiopathic hypogonadotropic
hypogonadism (nIHH), wherein HH occurs with a normal sense of smell.
The migration of GnRH-1ns proceeds along the axons of the terminal nerve and is known to depend on an
additional cell type, the olfactory ensheathing cells (OECs). However, what cellular and molecular mechanisms
underlie the development of the olfactory ensheathing cells, and the terminal nerve of mammals is still largely
unknown. The long-term goal of our research program is to discover the molecular mechanisms leading to
Kallmann syndrome and normosmic forms of niHH. By screening a cohort of human patients, we recently
discovered that a loss-of-function mutation in the gene encoding the transcriptional regulator Gli3 was associated
with KS. Moreover, our preliminary data show that Gli3 loss-of-function affects both OECs and terminal nerve
development in mice. Our central hypothesis states that Gli3 controls the development of the terminal nerve and
the development of the OECs in a dose-dependent fashion. Moreover, we postulate that and that the expression
of inductive factors in the developing olfactory system controls the formation of the OECs. Guided by our strong
preliminary data, we will here test our hypothesis through three specific aims: 1) To determine the dose-
dependent effects of Gli3 on terminal nerve development and gene expression. 2) To identify Gli3 gene targets
in the developing nose. 3) To discover the molecular mechanisms controlling the development of OECs. Our
innovative approach will exploit advanced single-cell transcriptomics, mouse genetics, imaging, CUT&RUN, and
bioinformatics to discover mechanisms underlying the development of the terminal nerve and OECs and the
formation of a functional GnRH-1 system. The proposed research is significant to human health since it will
advance and expand our understanding of KS and nIHH disease mechanisms in humans. The results from these
studies will improve diagnostic criteria and stimulate the development of novel treatments and therapeutic
strategies to improve the human condition.

Public health relevance
Project Narrative The proposed research addresses a relevant public health issue, as proper development of the neurons that secrete Gonadotropin-releasing hormone (GnRH-1) is essential for sexual development and function throughout life. In this project, we will elucidate molecular mechanisms controlling the development of olfactory support cells and the formation of the terminal nerve, processes essential for supporting the migration of GnRH-1-expressing neurons from the nasal area to the brain, a key event in establishing hormonal regulation. The proposed research is relevant to the mission of NICDH/NIH and will provide essential information needed for diagnosing and treating hypogonadotropic hypogonadism in humans.